Characterization of seasonal CoV immunity and operationalization of a novel controlled human infection model for the betacoronavirus OC43

Project Summary
Coronaviruses (CoVs) are large RNA viruses with a well-demonstrated potential for jumping host species. The
persistent threat of novel emergent CoVs necessitates a thorough understanding of CoV immunity and
preparedness for outbreak response. Four CoVs circulate seasonally, and SARS-CoV-2 has further
demonstrated the ability of coronaviruses to re-infect the same individual multiple times over a lifetime.
Whether CoV reinfections occur due to evolving viral epitopes or waning immunologic memory, and the role of
within host immunity for selection of novel variants remains a critical gap in understanding CoV immunity.
My long-term career goal is to become an independent and productive investigator in CoV and influenza
vaccinology, with a focus on controlled human infection models (CHIMs). A CHIM using the seasonal CoV
OC43, with low pathogenicity and structural similarity to the severe CoVs, will advance our understanding of
CoV immunology and provide a foundation for pan-CoV vaccine and therapeutic development in preparation
for future outbreaks.
Under the mentorship of Dr. Frieman, an expert in coronaviruses, and Dr. Neuzil, an expert in vaccine
development and controlled human infection models, I will pursue this goal of developing a CHIM with the
seasonal CoV OC43. A 2022 isolate of OC43 is undergoing ongoing development for use in a CHIM. However,
the assays to evaluate immunity to seasonal CoVs such as OC43 have historically been limited by relatively
poor growth in cell culture and lack of specificity by binding assays. Therefore, in Aim 1 I will use
pseudoviruses to develop a functional neutralization assay to assess immunity to seasonal CoVs, evaluating
the ability of sera from the past four decades to neutralize both recent and older OC43 pseudotyped viruses.
This will provide a mechanism to rapidly evaluate seasonal CoV neutralization with greater accuracy than
antibody binding alone. In Aim 2 I will build on a recent influenza CHIM conducted at the University of Maryland
to explore the diversity of influenza mutations occurring within individuals after a controlled infection, providing
novel explorations of the host factors that affect viral diversity. The viral genome analysis platform that we
develop in aim 2 will be essential for evaluating the viral diversity that develops during an OC43 CHIM. In Aim
3 I will develop the protocol for a seasonal CoV CHIM, with careful consideration for safety and endpoints that
will allow us to evaluate the effect of pre-existing immunity on symptomatic infection, viral shedding, and
duration of immune response.
A seasonal CoV CHIM has not been conducted for over 40 years, and today would allow us to characterize the
cellular and humoral correlates of protection, define host mediators of susceptibility, and directly assess
durability of immunity. This model system will be an essential tool for assessing variant-proof pan-coronavirus
interventions and will provide preparedness for the emergence of future novel coronaviruses.

Public health relevance
Narrative For both SARS-CoV-2 and influenza the difficulty of inducing long-lasting immunity that can protect against evolving viruses continues to complicate vaccine design. My proposed research will provide a functional assay to evaluate seasonal CoV immunity, characterize of the diversity of influenza mutations after a controlled human infection, and develop a protocol for a seasonal CoV controlled human infection model. These tools are necessary to advance the development of a controlled human infection model with the seasonal CoV OC43, which will provide an efficient mechanism to evaluate broadly protective CoV countermeasures.